Project 4: The BRCA Network in Medulloblastoma Responses to Replication Stress

The BRCA Network in Medulloblastoma Responses to Replication Stress (Project-4)
Abstract:
BRCA1 and BRCA2 are critical genes for the repair of DNA strand breaks (DSB) via homologous
recombination (HR). PALB2 functions to bridge BRCA1 with BRCA2. Due to the intimate relationship between
BRCA1, PALB2, and BRCA2, these genes and their coded proteins are considered the core of a “BRCA
network.” Cancers with BRCA mutations display unique molecular features of “BRCAness,” including
hypersensitivity to replication stress drugs. In addition to the core BRCA proteins, defects of other BRCA1/2-
associated genes often share the “BRCAness” characteristics.
Brain tumors are the leading cause of childhood cancer-related deaths, and medulloblastomas (MBs) account
for more than 60% of pediatric tumors. Current treatments of MBs mainly rely on local control by radiation in
combination with generic chemotherapy. Targeted therapy has not been vigorously considered for MBs.
Recently, it has been recognized that germline mutations in BRCA2 and PALB2, two of the core genes in the
“BRCA Network,” are among the top causes of MBs. Furthermore, widespread basal activation of DNA
damage signaling and excessive replication stress were common among different groups of MBs. Based on
genomic signatures, 20-30% of sporadic MBs, including those from MB groups 2, 3, and 4, likely bear HR
defects (HRD). These recent developments raise an important question of whether DNA damage repair
defects and replication stress represent common vulnerabilities of MBs to new therapeutic developments
targeting HRD. If so, how to efficiently identify the individual cases with HRD remains an issue.
In the preliminary studies, we established conditional knockouts of Brca1, Palb2, and Brca2 in embryonic
multi-potential stem and progenitor cells using the glial fibrillary acidic protein (GFAP) promoter-driven Cre
expression. For the first time, we demonstrated that conditional loss of Palb2 and Brca1 are effective inducers
of MBs, with a similar potency as that of Brca2 loss. An initial genomic characterization of these MBs exhibiting
“BRCAness” had identified several unique structural features that can be used to define the HRD status. By
treating the de novo MBs with a developing topoisomerase 1 inhibitor, we found it to be very effective to
extend the survival of mice with MBs. Thus, we hypothesize that MBs originated from BRCA defects have
unique genomic signatures to define the MBs with HRD, and targeted therapy of MBs with HRD will be more
effective than the current treatment regimens. In Project-4, we take advantage of our recent success in
establishing BRCA-related mouse MB models and strive to identify the genomic signatures associated with
HRD and to validate the MB “BRCAness” response to replication stress drugs. Aim 1 will identify the structural
and chromosome-context signatures that accurately reflect the HDR status in MBs exhibiting “BRCAness”.
Aim 2 will experimentally target the vulnerability of HRD in MBs and investigate the potential mechanism of
tumor recurrence after the treatment. The success of this study would effectively establish a new remedy for
MB treatment.

Public health relevance
Health Relevance: Recent studies have suggested that a large portion of the medulloblastomas may have a signature of homologous recombination defects (HRD) resembling the BRCAness tumors. However, the HRD has not been fully exploited for the targeted treatment of medulloblastomas. Our study will establish new genomic signature of HRD and validate new therapeutic approaches to target medulloblastomas with HRD.